Efficient Bioremediation of Environmentally Persistent Contaminants with Nanomaterial-Fungus Framework (NFF)

Project Summary
The recalcitrant and harmful chemicals such as PFASs (per- and polyfluoroalkyl substances),
endangers the environmental, wild-life, and human health profoundly. Among different
strategies, bioremediation was established as an effective and reliable solution for remediating
persistent environmental contaminants like PFASs. Fungi, such as basidiomycetes (i.e. white rot
fungi) are used in bioremediation of PFAS for their strong extracellular biocatalytic capacity with
great promise. However, several factors limit commercial applications: 1) need for nutrient
addition as the carbon source for the microbe; 2) need to immobilize fungus biomass as pellets
to prevent fungus dispersion onto reactor wall; 3) bacterial competition; 4) low efficiency due to
the low chemical availability to the fungal mycelium and slow fungus growth. The proposed
research will address the imminent challenges of remediating persistent and toxic environmental
contaminants using the uniquely designed Nanomaterial-Fungus Framework (NFF). The NFF is
a system that novel nano-materials create a biomimic scaffold where fungus can grow, and the
scaffold enriches trace level contaminants that fungus can degrade. We aim to unveil the
fundamental biodegradation mechanisms of the NFF system, which provides future guidance to
modify and improve the system. The engineered NFF system will offer a novel strategy that
applies toward a broad range of environmental pollutant bioremediation practices.

Public health relevance
Project narrative The research aims to address the significant challenges of persistent organic pollutants (POPs) remediation using Nanomaterial-Fungus Framework (NFF) through material design and mechanism study. The NFF contains a scaffold that absorbs trace level POPs rapidly, supports fungal growth, and stimulates the expression of oxidative enzymes for efficient bioremediation. The study will elucidate fundamental mechanisms for fungal bioremediation and offer an innovative stimulating material to enhance efficiency, enabling broad applications for remediation of diverse POPs.